Resource Core

Resource Core
PROJECT SUMMARY / ABSTRACT
The overarching goal of the Resource Core is to provide nonhuman primates in the quantity necessary to
meet the needs of Somatic Cell Genome Editing (SCGE) awardees. The Resource Core is embedded within
the established, comprehensive infrastructure provided by the California National Primate Research Center.
Rhesus macaques and marmosets will be available for SCGE investigator studies to be conducted in the
Genome Editing Testing Core and in order to generate data on efficiency, specificity, and safety of the
technologies developed. The Resource Core will accelerate translation of genome editing technologies from
studies in nonhuman primates into treatments for human diseases through the following Specific Aims: (1)
Provide nonhuman primates and related capabilities for investigator projects, and (2) Receive, breed, and
maintain reporter nonhuman primates. The Resource Core will provide at least 100 animals per year, which will
include wild-type and reporter rhesus and marmosets. The Resource Core will ensure investigators have the
quality and quantity of nonhuman primates necessary to meet their needs both through the provision of
currently available animals (wild-type), and through procurement and expansion of reporter strains that will be
provided to the Nonhuman Primate Testing Center from the SCGE Large Animal Production investigators.
Paired with a robust Coordination Component and the Genome Editing Testing Core, and within the context of
the infrastructure of the UC Davis California National Primate Research Center, the Resource Core will deliver
the animals needed to comprehensively assess the promise of new genome editing technologies developed by
SCGE awardees.